Development of a Multifunctional Rehabilitation Standing and Stepping Device for Persons with Parkinson's Disease

ABSTRACT
Tulip Make Me Move Desk, LLC is a startup medical device company based on R&D of the Multifunctional
Rehabilitation Standing & Stepping Device (MRSSD) prototype. The MRSSD is a standing desk with a
multidirectional moving tabletop that induces stepping movements while standing and simultaneously performing
motor and cognitive activities behind it. The MRSSD can serve as a stand-alone rehabilitation device or as an
adjunct to (physical therapy) PT. A prior very basic prototype of the MRSSD, called the “dynamic standing desk”
(DSK), has shown clinical feasibility of in-home use in persons with Parkinson's disease (PwP) showing an
average 2-hr daily use that was sustained over a 4-month period. Importantly, post-PT improvements in gait and
balance fucntions were sustained over this period while lost in a usual care control group. Movement of the DSK
, however, was limited to fixed speed and mediolateral excursions only. This precludes individualized therapeutic
use that is needed for the highly variable range of impairments in gait, balance, cognition, sarcopenia, and
common medical comorbidities, such as metabolic or vestibular changes and sarcopenia, seen in PwP.
Therefore, there is a need for symptom-specific rehabilitation goals in PwP that is also low cost, barrier-free and
unlike intermittent PT can be sustained in the long-term. We propose to develop a multifunctional rehabilitation
device that allows individualized targeting of specific morbidities in PwP, such as imbalance (emphasis on
mediolateral excursions), gait turning (emphasis on rotatory excursions), metabolic syndrome and sarcopenia
(emphasis on higher intensity and large excursions), vestibular changes (emphasis on anterior-posterior and
rotatory excursions), and cognitive impairment (emphasis on cognitive-motor dual tasking desktop activities).
Therefore, the MRSSD has the potential to provide a multifunctional, barrier-free, sustainable and low-cost
intervention to improve gait, balance, medical comorbidities and maintain cognition in PwP, who are at risk of
dementia, including comorbid Alzheimer’s disease. The MRSSD rehabilitation device will also fill a therapeutic
void by providing a rehabilitation standing desk that can uniquely integrate individualized multidirectional
stepping therapy with routine activities of daily living in the home environment thereby enabling long-term
sustained utilization rates. The goals of this STTR proposal are (i) to develop a next-generation MRSSD
multidirectional and variable range and intensity mobility, metabolic and cognitive-motor rehabilitation
therapy device, (ii) collect user acceptance and in-lab feasibility of repeated use data & (iii) conduct a
pilot controlled clinical trial to generate data to power a large-scale clinical trial in Phase II. The long-term
goal of this STTR is to provide a cost-effective, easy to implement a sustainable multi-purpose rehabilitation
option for patient populations with mobility, metabolic and cognitive impairments.

Public health relevance
NARRATIVE Persons with Parkinson’s disease may manifest a highly variable range and presence of impairments in gait, balance, cognition and common medical comorbidities, such as frailty and metabolic changes. Tulip Make Me Move Desk, LLC, proposes to develop a multipurpose rehabilitation standing and stepping device that promotes stepping movements while allowing simultaneous use of routine desktop activities in the user's own home environment that allows individualized therapies targeting specific components that contribute to gait, balance and cognitive problems in persons with Parkinson’s disease. .